Label free imaging of blood smears and tissue biopsies

DESCRIPTION (provided by applicant): This exploratory project is aimed at investigating the potential of newly developed optical interferometric technique that we developed- Spatial Light Interference Microscopy (SLIM)-- for characterizing blood smears and tissue biopsies. SLIM is label-free and uniquely sensitive to refractive index modifications brought to the biospecimen by disease development . If successful, in the long-run, i.e. 5-10 years period, we anticipate that this label-free approach to imaging biospecimens will provide faster access to clinically-relevant data, as it bypasses most of the histology preparation process, e.g. staining. Further, due to its exquisite sensitivity to structural changes in the tissue, SLIM will provide a greater wealth of information than common histology, which should aid the pathologist in reaching a faster, more accurate diagnosis. The exploratory stage project will have the following specific aims: develop advanced, high-throughput instrumentation, perform proof-of principle studies on blood smears with focus on several specific diseases, and image biopsies of normal and three types of cancers (breast, prostate, and lung).

Public health relevance
NARRATIVE This exploratory project is aimed at investigating the potential of newly developed optical interferometric technique that we developed- Spatial Light Interference Microscopy (SLIM)-- for characterizing blood smears and tissue biopsies. SLIM is label-free and uniquely sensitive to refractive index modifications brought to the biospecimen by disease.